Hair Cell Polarization and Sensory Bundle Development

PROJECT SUMMARY/ABSTRACT
Deafness at birth frequently originates from defects in the development of sensory cells in the inner ear. Likewise,
hearing degradation during life frequently follows damage sustained by these cells after normal development. In
each case, a particularly susceptible cellular compartment is the hair bundle, a specialized structure in each
sensory cell that detects and relays sound-borne vibrations. The hair bundle is an array of actin-based membrane
protrusions, or stereocilia, precisely organized in rows of graded heights. Although the tiered architecture of the
hair bundle is fundamental for sensory function, the molecular machinery required for its assembly during
development and for the maintenance of its exact dimensions during life remains obscure. To address these
open questions, we propose to exploit knowledge gained from our ongoing investigations of the GPSM2-Gαi
protein complex in mouse. Absence of the scaffold protein GPSM2 or inhibitory G proteins (Gαi) result in
defective hair bundle assembly, a likely etiology for congenital hearing loss in Chudley-McCullough syndrome.
The GPSM2-Gαi protein complex is first enriched on one side of the nascent hair bundle only (the bare zone),
and then enriched at the tip of stereocilia in the adjacent first row, a distribution required for proper stereocilia
placement and elongation, respectively. We showed that the Myosin-15A motor transports GPSM2-Gαi to
stereocilia tips, where in turn GPSM2-Gαi increases Myosin-15A amounts compared to other rows to define the
tallest identity of the first row. Based on detailed preliminary data, we hypothesize that, 1) As yet unstudied Gαi
regulators act as upstream cues to selectively enrich the GPSM2-Gαi complex only in the bare zone region of
the apical membrane and only in a single row of stereocilia. 2) Prior GPSM2-Gαi enrichment on one side of the
nascent hair bundle is the mechanism by which GPSM2-Gαi becomes restricted to abutting stereocilia in the
first row, giving the hair bundle its tiered architecture. 3) Continued enrichment of GPSM2-Gαi at stereocilia tips
after development has a role in maintenance of proper stereocilia height and girth in adult hair bundles. To test
these hypotheses, we will: 1) Characterize the role of a negative Gαi protein regulator that we already established
as a new deafness gene critical for GPSM2-Gαi complex localization and hair bundle morphogenesis. 2) Use a
new chemical protein labeling technology and new reporter mouse models to track discrete pools of GPSM2-
Gαi and follow their dynamic trafficking to the bare zone and stereocilia tips in time. 3) Inactivate GPSM2-Gαi
function in structurally and functionally normal hair bundles in adults, and monitor stereocilia dimensions,
stereocilia actin dynamics and mouse auditory function. A thorough understanding of the mechanisms that shape
and preserve hair bundles will help interpret and design treatments for sensory cell dysfunction, the principal
cause of hearing loss.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Hearing at birth, as well as lifelong hearing preservation, requires sensory cells in the inner ear to develop and maintain a motion-sensing compartment that detects sound-borne vibrations. This project seeks to understand how this compartment acquires its unique slanted architecture required for sensory function, and how this architecture is preserved during life despite wear and tear. Accomplishment of the proposed research will help the interpretation and design of treatments for auditory dysfunction.